Circadian Signatures in Chronic Lung Disease

PROJECT SUMMARY/ABSTRACT
Circadian rhythms are an important yet poorly understood feature of chronic lower respiratory disease. In airway
diseases such as asthma and chronic obstructive pulmonary disease (COPD), nocturnal exacerbations are a
disease-defining characteristic in which normal circadian swings in airway resistance are pathologically
amplified. Circadian rhythms are generated by a cell-autonomous molecular clock that orchestrates tissue-
specific rhythms in gene expression, leading to oscillations in physiology including in the lung. Research
suggests that molecular clock function specifically within airway epithelial cells regulates innate antimicrobial
responses. Such responses are critical in chronic lung disease because they may determine whether an
encounter with a virus or other pathogen triggers a clinical exacerbation. Currently, there is no information on
the circadian regulatory program within the human lung and how chronic disease might rewrite this regulation to
drive pathogenesis. Here we show that chronic lung disease alters rhythms in circadian clock gene expression
in human bronchial epithelial cells (HBECs) from patients. We demonstrate that HBECs express circadian
transcriptomes encompassing hundreds of genes and exhibit disease-specific patterns that can be further altered
by acute viral infection. As such, we hypothesize that chronic airway disease reprograms circadian gene
expression in airway cells thereby influencing virus susceptibility. The overarching goal of this project is to
translate circadian biology into disease-modifying treatments for patients with chronic airway disease by
mitigating or preventing virally triggered clinical exacerbations. Aim 1: Identify disease-specific circadian
gene expression programs regulating antiviral responses in asthma and COPD patients. Using a unique
repository of HBECs developed by our group that were isolated from human lung explants, we will determine the
circadian transcriptomes of HBECs obtained from asthma and COPD patients and compare these to donors
without chronic airway disease. In parallel, we will phenotype HBECs in terms of their susceptibility to acute
influenza A virus (IAV) infection in the presence or absence of circadian clock disruption. Observations in HBECs
will be backed by single cell imaging of circadian rhythms and a first-of-its-kind analysis of in vivo human airway
circadian gene expression using serial airway brushing samples obtained from organ transplant donors after
brain death while they await organ procurement. Aim 2: Discover evolutionarily conserved circadian
reprogramming in chronic airway disease. We will use a well characterized mouse model of asthma/COPD-
like airway remodeling with known clock regulation of antiviral responses. Using this model, we will examine lung
circadian reprogramming of gene expression and leukocyte trafficking by chronic airway disease and determine
the dependency of this program on the airway epithelial cell peripheral clock. These studies will be backed by
in vivo imaging of airway clock gene expression in mice using bioluminescent reporters.

Public health relevance
PROJECT NARRATIVE This project will determine how chronic diseases like asthma and COPD rewire the way cells within the lung use temporal (circadian) information to fight common viral infections. Because viral infections are a major cause of clinical deterioration in patients with asthma and COPD, applying the knowledge gained by this project could lead to fewer hospitalizations for patients, improved quality of life, and broad benefits to public health. The information produced by this project could ultimately help doctors identify patients with a heightened susceptibility to respiratory viruses and prompt a change in how they approach cold and flu prevention for these at-risk individuals.